Evaluating the Impact of a Publicly Funded Partial Hospitalization Program in Reducing Overdose Risk in Philadelphia

ABSTRACT
Drug overdose continues to be a leading cause of injury death in the United States with rates rising
significantly over the past two decades (Spencer et al., 2024). Although the first wave of the overdose crisis
was attributed to the misuse of prescription opioids (Wave 1), subsequent waves have been driven by heroin
(Wave 2), fentanyl (Wave 3), and fentanyl and stimulants (Wave 4; Ciccarone, 2021). In 2022, 107,941 drug
overdose deaths were reported nationally, with the majority involving fentanyl and other synthetic opioids
and/or stimulants (e.g., cocaine, methamphetamine; Spencer et al., 2023, 2024). Furthermore, anyone who
uses drugs is at risk for overdose given the introduction of fentanyl and other adulterants into the illicit drug
supply (Spencer et al., 2023). Provisional 2023 data suggest there was an overall decrease in overdose deaths
nationally for the first time since 2018; however, decreases were not observed within all populations. In fact,
increases in overdose deaths were observed among Black and Hispanic groups (Ahmad et al., 2024). Trends
in Philadelphia, ranked third in number of fatal overdoses among big cities (Niamatullah et al., 2022), mirror
those seen nationally. In 2017, as part of the Mayor’s Task Force to Combat the Opioid Epidemic in
Philadelphia (City of Philadelphia, 2017), Public Health Management Corporation established Pathways to
Recovery (PTR), Philadelphia’s only publicly funded partial hospitalization program for individuals with co-
occurring substance use and mental health diagnoses (American Society of Addiction Medicine [ASAM] 2.5
level of care). PTR is located in Kensington, the area considered by many to be the epicenter of the epidemic
in Philadelphia. As a secondary prevention program, PTR is designed to identify individuals appropriate for this
intensive (20+ hours per week) community-based treatment and engage them in comprehensive care to
address not only their substance use and mental health problems but also social determinants of health that
may impact their substance use and overall health. The proposed 3-year mixed methods evaluation (Funding
Option A: Implement and rigorously evaluate strategies) will compare 6-month outcomes of PTR-appropriate
(i.e., requiring a 2.5 level of care) individuals who enroll in the program (n = 100) to those who do not (n = 100)
using propensity score weighting procedures to equate the two samples. Participants will complete
comprehensive biopsychosocial assessments and urine drug screens at baseline and months 3 and 6 post-
baseline. In addition, a focus group will be held with 10 individuals who received PTR services. The specific
aims are to (1) Evaluate the impact of PTR in reducing rates of fatal and non-fatal overdoses; (2) Evaluate the
impact of PTR in reducing substance use and improving health-related quality of life, mental health functioning,
and recovery capital; (3) Evaluate the impact of PTR in addressing social determinants of health including
employment and housing status; and (4) Collect qualitative data from program participants to inform
conclusions and identify areas for program improvement. If found to be effective, the PTR secondary
prevention approach could serve as a model for other cities and municipalities.

Public health relevance
PROJECT NARRATIVE There is a clear need for effective secondary prevention strategies to address the current overdose crisis as overdose continues to be a leading cause of death in the U.S., fentanyl and stimulants are driving this trend, and particular groups of individuals (e.g., racial and ethnic minorities) are being disproportionately affected. The proposed study will evaluate the effectiveness of Pathways to Recovery (PTR), the only publicly funded partial hospitalization program in Philadelphia for individuals with co-occurring substance use and mental health disorders, in reducing overdose risk, improving other important biopsychosocial outcomes, and reducing disparities in disease burden. If found to be effective, the PTR model could be adopted by other cities and municipalities as an effective secondary prevention strategy to address the overdose crisis, thereby having a significant positive impact on public health.